Personalized Antimicrobial Combinations to Combat Resistance

Abstract
The prevalence of multidrug-resistance in Gram-negative bacteria (e.g., Pseudomonas aeruginosa,
Acinetobacter baumannii), is rising at an alarming rate, rendering many (if not all) antibiotics ineffective when
used alone. The rate of new drug development is unlikely to keep pace with the increase in multidrug
resistance. Combination therapy is often used clinically as a last resort. However, considering the numerous
possibilities, combination therapy are selected by clinicians mostly based on anecdotal experience and
intuition. A robust method to guide rational selection of combination therapy would be crucial to delay returning
to the pre-antibiotic era.
Our long-term goal is to optimize clinical use of antibiotics to combat the emergence of resistance. The
objective of this application is to develop a novel precision medicine platform (monitoring device and data
processing algorithm) that will guide the design of combination therapy. If short-term experimental data can be
used to predict the response of patient-specific bacteria to clinically relevant antibiotic exposures, effective
treatment strategies could be formulated rationally by identifying the best possible combination, thus guiding
clinicians in the selection of combination therapy. We plan to accomplish the objective of the application as
follows: (1) enhance testing throughput for optimal clinical application; (2) identify useful antibiotic combinations
against multidrug resistant bacteria; and (3) maximize the potentiating effect of agents targeting specific
mechanisms of resistance (e.g., β-lactamase inhibitors) in drug-resistant bacteria.
In this application, the proposed approach will be illustrated by experimental data with P. aeruginosa, A.
baumannii and Klebsiella pneumoniae. However, the proposed model-based system is not confined to a
specific antimicrobial agent - pathogen combination. It could be extrapolated to other antimicrobial agents
(e.g., antibacterials, antimycobacterials and antiretrovirals) with different mechanisms of action, as well as to
other pathogens (e.g., Staphylococcus aureus, tuberculosis and HIV) with different microbiological
characteristics.

Public health relevance
Project Narrative As the prevalence of multidrug-resistant bacteria increases, available antibiotics are no longer effective when used alone. It is critical that we develop effective treatment strategy (combination therapy) for multidrug- resistant infections. Otherwise, we are at risk of returning to the pre-antibiotic era in the not too distant future.